Collaborative on Food with Arsenic and Associated Risk and Regulation

? DESCRIPTION (provided by applicant): The Collaborative on Food with Arsenic and associated Risk and Regulation (C-FARR), sponsored by the Dartmouth College Toxic Metals Superfund Research Program and the Children's Environmental Health and Disease Prevention Research Center, is working to address important issues surrounding arsenic in food. C-FARR proposes to hold an invitational workshop with the following core aims: 1. to develop a network of scientists who study the fate of arsenic in food and the resulting exposure to humans; 2. to facilitate communication between stakeholders and scientists about the important questions relevant to public health policy and regulation of arsenic in food in the U.S. and globally; 3. to provide a forum for scientists working on arsenic including biologists, environmental chemists, agricultural and health scientists, risk scientists, epidemiologists, nutritionists and pediatricias to communicate their results to other investigators and facilitate an interdisciplinary exchange of information that will accelerate relevant science; 4. to identify key questions and knowledge gaps about arsenic in food and exposure to humans via consumption of rice and other foods containing arsenic, and to facilitate the analysis of existing data to address those questions; and, 5. to produce a series of manuscripts and applicable data sets addressing key questions and knowledge gaps, which will form the foundation for publication of a special issue of a peer-reviewed journal and related translation materials to inform policy for the regulation of arsenic i food. The workshop will be designed to convene authors (researchers studying arsenic in soils and seawater, plant uptake, food exposures, and their impacts on human health), policymakers and stakeholders in a collaborative setting to: 1) hear from stakeholders and policymakers about the latest developments and needs pertaining to arsenic related policy issues; 2) work together to identify gaps in arsenic science and related policy questions that should be addressed in synthesis papers; 3) present paper outlines to the group and continue dialogue for shaping papers and questions; 4) provide opportunities for paper authors to break out in groups to work on paper outlines and content; 5) discuss stakeholder perspectives for each paper and recruit additional authors; and 6) discuss translation products, outreach and target audiences.

Public health relevance
PUBLIC HEALTH RELEVANCE: The existing scientific research on arsenic in food and risk to human health is growing at the same time that international and national policy approaches are being developed. The time is optimal for translating the science of arsenic in food, discussing current developments and needs pertaining to arsenic related policy issues and providing syntheses of specific areas of arsenic research to policy makers so that the decisions about environmental fate and human exposure to arsenic from food can be based on the most rigorous and current scientific research. The proposed workshop would bring together scientists of multiple disciplines who all work in fields of food arsenic research with stakeholders and policy makers to summarize and synthesize the current research that would provide the scientific basis for these important policy decisions.